Characterization and targeting of a novel pathway promoting Parkinson’s Disease

PROJECT SUMMARY/ABSTRACT
It is well established that many age-related neurodegenerative diseases are driven by the aggregation of
improperly processed or misfolded proteins. For example, the aggregation of α-synuclein (α-Syn) within Lewy
bodies results in a constellation of diseases referred to as synucleinopathies. These include Parkinson’s Disease
(PD) and Parkinson’s Disease Dementia (PDD). The mechanisms leading to neuronal loss in PD and PDD
remain unknown, however, neuroinflammation is thought to be a common feature, including microglial activation
in the early stages of neurodegeneration, and evidence from both animal models and patient studies supports
the involvement of the adaptive immune response and α-Syn reactive T cells. In this application we identify a
previously unrecognized pathway promoting α-Syn-induced neuroinflammation and neurodegeneration. We
show that this pathway is mediated by the protease, tissue plasminogen activator (tPA) through an interaction
with the N-methyl-D-aspartate receptor-1 (NMDAR1). Using an AAV-α-Syn mouse model we find that tPA levels
in the SN are significantly increased in mice overexpressing α-Syn, and that tPA deficiency protects
dopaminergic neurons from degeneration and reverses behavioral deficits induced by α-Syn neurotoxicity. The
action of tPA is independent of its proteolytic activity but can be prevented by treatment with Glunomab, a
blocking antibody that binds the NMDAR1 and selectively inhibits its interaction with tPA. Both tPA deficiency
and Glunomab treatment prevent neurodegeneration, normalize behavior, reduce microglia activation, and
inhibit T-cell infiltration. Based on these preliminary data we will test the hypothesis that in response to neuronal
overexpression or aggregation of α-Syn increased expression of tPA promotes neuroinflammation through
interaction with the NMDAR1 and recruitment of cytotoxic lymphocytes resulting in neurodegeneration and
leading to PD and PDD. We will test this hypothesis in two different synucleinopathy models, an AAV-α-Syn
mouse model of PD, and an α-syn preformed fibril (α-syn PFF) model of PDD in mice.

Public health relevance
PROJECT NARRATIVE Many age-related neurodegenerative diseases are driven by the aggregation of improperly processed or misfolded proteins, and aggregation of the protein α-synuclein is associated with the development of Parkinson’s disease and Parkinson’s disease dementia. This project will examine how the protein tissue plasminogen activator, through its binding to the N-methyl-D-aspartate receptor-1 promotes the development of Parkinson’s disease and Parkinson’s disease dementia.